Core--Digital image microscopy/flow cytometry

DESCRIPTION: (Applicant's Description) Core C, the Digital Image Microscopy/ Flow Cytometry Core, will provide services for Projects 1-5. A unique aspect of the core is the DIMSCAN system, which is a custom image analysis system that we developed for quantifying cytotoxicity or growth inhibition over a 4-5 log dynamic range. The core also has a new Coulter Elite flow cytometer and considerable expertise in flow cytometry. The uses of this core by program investigators are as follows: (1) Digital Image Scanning Microscopy (DIMSCAN). (a) Maintain DIMSCAN instrument and assay system in working order for use by program investigators for experiments dealing with chemotherapeutic agents and retinoids (Project 4), ADCC (Project 3), integrin antagonism and fenretinide (Project 2) and cell migration/invasion (Project 1). (b) Provide instruction in use of DIMSCAN, assist in designing experiments and assist in analysis of data. (2) Flow Cytometry. (a) Operate and maintain flow cytometer to analyze specimens from program investigators. (b) Provide instruction on conduct of flow cytometry experiments, assistance with analysis of data, and participate as needed in design of experiments for program investigators. Specific assays available include: Cell cycle analysis (DNA or DNA + BrdU incorporation) (Project 4); Quantification of cell surface antigens (Projects 2, 3, and 5) of Quantification of cytotoxicity (Project 3); Apoptosis (Projects 2 and 4); Measuring free radicals/H202/02- (Projects 3 and 4); Cell sorting (Projects 1, 2, and 3).